DEVELOPMENT OF IN VIVO PROTON NMR SPECTROSCOPY AND SPECTROSCOPIC IMAGING

The purpose of this project is the noninvasive evaluation of regional biochemistry, the human brain in particular. Programs developed in the NMR Center are now considered state-of-the-art. Software has been requested and installed at MGH, Boston; McLean Hospital, Boston; Univ. of Madrid, Spain; Univ. of Sydney, Australia; Univ. of Utah; Univ. of Kyoto, Japan; Univ. of Albany, NY; and University of Caen, France. Applications are ongoing in the fields of acute stroke, adrenoleukodystrophy, glioma and lymphoma tumors, and schizophrenia.